Astrocytes as governing pathological drivers of neurovascular dysfunction in AD

Astrocytes as governing pathological drivers of neurovascular dysfunction in AD
Abstract:
Alzheimer’s Disease (AD) is a progressive and irreversible neurodegenerative disease, characterized by
cognitive decline. The pathogenesis of AD is complex, and the etiology has yet to be fully elucidated. The
pathological manifestations of AD involve amyloid (Abeta) plaques and neurofibrillary tangles (NFTs), as well
as a significant synaptic loss and neuronal degeneration, and a neuroinflammatory process accompanied by
microglial and astrocytic activation. Specifically, the role of astrocytes in AD is very limited, although their
contribution is likely crucial in the initiation and progression of AD. Astrocytes undertake numerous
fundamental functions for the general homeostasis of the central nervous system, maintaining normal brain
activities, and are key players in aging and dementia. Astrocytes are vital for maintaining the health of the
neurovascular unit such as (but not limited to): contributing to synaptic transmission, blood flow dynamics,
neurovascular coupling, glutamate homeostasis, potassium homeostasis, osmotic regulation, removal of
interstitial waste products from the parenchyma, contributing to blood-brain barrier (BBB) function, sleep health
and wakefulness. Astrocytes play an important role in functional hyperemia, in which local increases in blood
flow meet the metabolic demands of increased neuronal activity. These findings highlight astrocytes as a
central player within the neurovascular unit. Astrocytes demonstrate functional activity through calcium
signaling, however, the role of astrocytic calcium signaling pathophysiology in neurovascular unit dysfunction
remains poorly understood. We will test our governing hypothesis that astrocytic calcium signaling
pathophysiology is a major governing pathological driver of neurovascular unit dysfunction in AD and
an exciting and novel disease modifying therapeutic target. We have powerful in vivo tools and expertise
to thoroughly test this hypothesis in vivo with multiphoton microscopy. We will image calcium concentrations
and dynamics using genetically encoded calcium reporters targeted to astrocytes or neurons in all of the
cellular compartments within single astrocytes, along with amyloid deposits, the vasculature, and neuronal
calcium signaling to identify the mechanism of the astrocyte pathophysiology observed in mouse models of
AD. We will interrogate the system through observations of plaque proximity, test the direct role of soluble
Abeta oligomers, and use a functional hyperemia approach based on a visual stimulation paradigm to evaluate
the deterioration of the function of the complete neurovascular unit. These experiments in total will determine
which components of the neurovascular unit are compromised and when over the lifetime of the mice.
Ultimately, this will guide decisions for the development of novel therapeutic approaches in AD.

Public health relevance
Alzheimer’s disease (AD) is the result of cellular and network dysfunction at a variety of levels. A key cellular regulator of brain function, astrocytes, are involved in maintenance of synaptic function, neuroinflammation, and the regulation of blood flow to meet the demands of neuronal activity. Astrocytes are intimately connected to other astrocytes, neurons and the vasculature, and communicate through calcium signaling that can be observed through imaging in the brain of living mouse models of AD throughout their lifespan during the progression of AD pathology.